Program to Increase Diversity in Cardiovascular Health Related Research

? DESCRIPTION (provided by applicant): This proposal aims to continue support for the Program to Increase Diversity in Cardiovascular Health-Related Research (PRIDE-CVD) at the State University of New York (SUNY) Downstate Medical Center in Brooklyn, New York. The goal of the PRIDE-CVD is to instruct scientists/clinicians in multidisciplinary approaches to research in cardiovascular health disparities using Brooklyn as a living laboratory. The PRIDE-CVD has been in existence for 8 years and has trained 52 scholars. More than a half of the scholars have secured funding from NIH after 2 years of their summer training and 30% were promoted from Assistant Professor to Associate Professor. To continue to build on this success and years of experience, the renewed Program has the following Specific aims: 1: To select qualified underrepresented scientists and clinicians who have potential to contribute to the state of current knowledge in cardiovascular disease research; 2: To train a diverse group of scientists in multidisciplinary research methods to address cardiovascular health disparities; 3: To mentor program participants with the goal of helping them submit a research grant application; 4: To provide underrepresented scientists with intensive individualized training and guidance in grant writing and peer review in order to enhance their capacity for success in their research careers; 5: To evaluate long-term effectiveness of PRIDE-CVD. The PRIDE-CVD at Downstate is characterized by: 1) its partnership with minority-led community-based organizations with expertise on health disparities; 2) the living laboratory of Brooklyn, New York, an urban setting in which to conduct health disparities and CVD research; 3) a well renown faculty roster with a high number of minority members; 4) a historical context providing eight years of experience in training and supporting minority scholars. It is expected that the PRIDE-CVD will continue to contribute significantly to improving the pool of highly-capable minority professionals in cardiovascular health research.

Public health relevance
This proposal aims to continue training and mentoring underrepresented minority scientists and those with disabilities by enhancing their research skills in cardiovascular health disparities. The ultimate goal to increase diversity among the ranks of underrepresented scientists is an important step towards alleviating health disparities. In the eight years since its inception at Brooklyn SUNY Downstate Medical Center, the program has trained 52 minority researchers, many of whom are funded or on their way to obtaining research funding and pursuing independent academic careers.